Psychosocial Stress Effects on Regenerative Medicine Therapies for Lower Urinary Tract Disorders in Nonhuman Primates

This proposal is a response to PAS-19-241, Stimulating Urology Interdisciplinary Team
Opportunity Research, the aim of which is to promote innovative, high-quality,
interdisciplinary research relevant to the NIDDK. Importantly, this PAS and a prior
workshop identified psychosocial factors in women with urinary incontinence as an important
knowledge gap. To this end, we bring together experts from behavioral sciences, urology, molecular
pathology, and regenerative medicine to explore further our initial findings that
socially subordinate female monkeys do not respond as well to cell therapy for urinary incontinence
as their dominant counterparts. We now propose a more comprehensive approach to assess (a)
sympathetic nervous system (SNS) arousal, hypothalamic-pituitary-adrenal (HPA) activation, and
impaired ovarian function in socially housed monkeys; and (b) the likely pathways by
which social subordination stress affects structural and functional regeneration within
the urinary sphincter. Two likely pathways through which social subordination stress may
modulate these processes are cortisol and SNS effects on tissue and cell damaging inflammation and
estrogen-deficiency-associated inhibition of cell mobilization. These processes are not mutually
exclusive and may involve the CXCL12/CXCR4 signaling pathway. Based on our previous
studies and the published literature, our central hypothesis is that psychosocial stress
inhibits the regenerative effects of cell therapy by reducing the mobilization of tissue
healing bone marrow progenitor cells, and increasing the presence of hematopoietic tissue
damaging inflammatory cells in the urinary sphincter. This hypothesis will be tested in a
prospective, randomized, nonhuman primate preclinical trial using our well-characterized female
cynomolgus monkey model of psychosocial stress due to social subordination, and our model of
intrinsic urinary sphincter deficiency. Our Specific Aims are to determine the effect of
social status on: 1) the structural (cellular, acellular, vascular, innervation) and
functional (urinary sphincter and bladder) effects of autologous skMPC therapy in female
primates with ISD; 2) The injected lenti-M-cherry+ skMPC cell retention in, and lenti GFP+ labeled
bone marrow cell mobilization to, the urinary sphincter of dominant and subordinate monkeys; 3) The
effect of social subordination stress on abundance and polarization of inflammatory
cells and associated molecules in the urinary sphincter; and 4) Whether social status
effects on cell therapy-induced tissue regeneration are mediated by behavioral stress, SNS,
HPA, or ovarian function. The results of this translational research will promote understanding
of limitations and potential future regenerative medicine strategies for women with urinary
incontinence.

Public health relevance
This research will: promote understanding of how psychosocial factors impinge on cell therapy; enhance translation from preclinical to clinical studies; and elucidate how to increase the efficacy of cell-based therapies on urinary sphincter deficiency-associated stress urinary incontinence.